The role of Sirtuin 5 in acute kidney injury

ABSTRACT
Acute kidney injury (AKI) occurs in nearly 1 of 5 hospitalized patients and is associated with increased morbidity
and mortality across all ages. Many AKI patients will recover kidney function post-injury but then progress to
chronic kidney disease (CKD). The mechanisms are poorly understood and there are currently no effective
therapies to prevent, limit, or reverse the tissue damage. There is a critical need to identify mechanisms involved
in the pathogenesis of AKI. Our long-term goal is to elucidate these mechanisms and leverage them for new
therapies to limit AKI and prevent the transition to CKD. Proximal tubule epithelial cells (PTEC), a major site of
damage during AKI, are very metabolically active and rich in mitochondria. Mitochondrial metabolism causes
increased reactive oxygen species (ROS) which has been implicated in both ischemia-reperfusion injury (IRI)
and cisplatin-induced nephrotoxicity. Modulating mitochondrial function during AKI is an attractive, but thus far
unachievable, strategy. Our central hypothesis is that loss of the mitochondrial sirtuin lysine deacylase Sirt5
leads to shifts in PTEC metabolism that protects against AKI. This is supported by preliminary data showing
protection against both IRI and cisplatin-induced AKI in global Sirt5 knockout (Sirt5-/-, Sirt5+/-) mice in vivo and
in vitro as well as in primary human PTEC with siRNA knockdown of Sirt5. Further data support our proposed
mechanism of protection in which Sirt5-/- PTEC exhibit a form of metabolic adaptation characterized by a shift
of fatty acid oxidation (FAO) from mitochondria to peroxisomes. Peroxisomes have previously been linked to
renoprotection in other animal models, most likely due to their ability to eliminate ROS. In Sirt5-/- kidneys,
peroxisomes are more resistant to damage during AKI. Our central hypothesis will be tested with two aims. Aim
1 will define the specific site of Sirt5 action during kidney injury with a particular focus on PTEC. While aim 2 will
drill down on the renoprotective role of metabolic FAO inhibition coupled with stimulation of peroxisomal fatty
acid oxidation during kidney injury. Both aims will utilize a rigorous, mechanistic approach that combines in vitro
and in vivo models. In vivo studies in mice will use both global Sirt5-/- PTEC-specific knockout of Sirt5 as well
as global and PTEC-specific knockout of LCAD-/- (key mitochondrial FAO enzyme). In vitro studies will use
isolated primary mouse and human PTEC as well as genetically manipulated mouse and human cell lines.
Human AKI will be modeled in mice by unilateral ischemia-reperfusion injury and single high dose treatment with
the nephrotoxin cisplatin. We have also optimized a CKD model using a unilateral ischemia-reperfusion injury
model. This project will significantly advance the field by opening up new therapeutic avenues where Sirt5 can
be pharmacologically inhibited or its renoprotective mechanism can be harnessed in the context of AKI to protect
against injury and block the progression to chronic kidney disease.

Public health relevance
Project Narrative: Acute kidney injury is one of the most common kidney pathologies and a common cause of chronic kidney disease leading to dramatically reduced life expectancy. To date there are no clinically proven therapies for treating acute kidney injury. This application identifies novel mechanisms that protects the kidney against acute kidney injury and has significant therapeutic potential to treat the ever-growing number of acute kidney injury patients.